Central Biochemistry Laboratory of the CKID Consortium

The Central Biochemistry Laboratory (CBL) serves the subjects and investigators of the continuing Prospective
Study of Chronic Kidney Disease in Children (CKiD). The CBL provides participating clinical sites with
protocols, kits, reagents, supplies, and transportation required for collecting blood and urine for analysis at
URMC and other laboratories. Blood analytes include electrolytes, BUN, creatinine, glucose, calcium,
phosphorus, albumin, uric acid, lipid screen, hsCRP, intact PTH, and cystatin C. Urine analytes include
creatinine and protein. The CBL has determined optimal conditions for transporting these analytes, and
provides ambient shippers for each visit and quarterly dry ice shippers for frozen specimens. The CBL also
provides the kits and instructions for collection and shipment of blood, plasma, sera, urine, hair, and nail
samples to NIH repositories. Biochemical data from each CKiD visit are reviewed and entered into Nephron,
the CKiD data base. The CBL provides training at annual CKID meetings and is readily available to provide
information, instruction, and support during CKiD visits. The CBL contributes expertise in performing
biochemical assays and clinical interpretation of the results. The CBL collaborates regularly with the Data
Coordinating Center to provide expertise regarding laboratory medicine, optimizing GFR studies and
generating GFR estimating equations, maintaining the Manual of Procedures, assuring the quality control of all
assays, and providing continuity of biochemical assays through changes in instrumentation. The CBL
participates in all Steering Committee meetings and conference calls and collaborates with investigators in the
generation of abstracts, presentations, and manuscripts. The proposed aims of the CBL center on continuing
to provide accurate, precise, and efficient measures of biochemical measurements of general kidney health
and contribute as a scientific partner to further the research agenda of the CKiD Consortium. The CBL will
continue to provide the laboratory kits for collection, handling, and transport of samples, accurately receive,
process, and analyze these samples on a day-to-day basis, and provide timely data entry into Nephron. The
CBL has established a new subcontract with the UMN ARDL that will assure accurate measurement of iohexol
concentrations (and hence GFR) during this project period. Accordingly, the CBL will continue to develop and
optimize GFR estimating equations using conventional biomarkers in Cohort 3 subjects and other participants
with Stage 1 CKD, and in those having received a kidney transplant. The CBL has completed work on concept
sheets showing that hyperuricemia is associated with more rapid renal progression and that microalbuminuria
is no better predictor of renal progression than is urinary protein. The CBL will next examine beta trace protein
to determine if it is useful in predicting GFR. The long term goal is to better characterize the CKiD population
biochemically, maintain the integrity of the data, optimize the collection of specimens in a manner that
maintains recruitment and retention of CKiD subjects, and generate relevant publications.

Public health relevance
The Central Biochemistry Laboratory of the continuing Prospective Study of Chronic Kidney Disease in Children (CKiD) provides participating clinical sites with protocols, subject- and visit-specific kits, reagents, supplies, and transportation required for performing kidney function tests and collecting blood and urine for analysis at URMC, Repositories, and other laboratories. Laboratory data are entered into the web-based database, Nephron. Also, the Central Biochemistry Lab provides training to coordinators and investigators, expertise to the CKiD study in regard to laboratory tests and the handling of blood, urine, and other human materials, and collaborations with the other CKiD investigators.